Engaging communities to develop and evaluate communication strategies for HIV vaccine and prevention uptake among Black women in the Southern US

Project Summary
This proposal addresses NIMH’s call for HIV vaccine preparedness and “HIV vaccine-related” communication
research (Notice of Special Interest NOT-MH-21-105). Though vaccines may be years away, the NOSI
recognizes that the time to conduct rigorous HIV vaccine communication research is now – to advance the
basic science of effective HIV vaccine messaging and get ahead of misinformation.
HIV disproportionately impacts young Black women living in the Southern US. Black women make up 13% of
the female population in the US, yet make up 54% of new HIV infections among women in the US. These
disparities are most extreme in the South, where black women account for 72% of new HIV infections among
women. These data highlight the urgent need to develop and scale-up biomedical HIV prevention strategies
centered on the unique needs of Black women in the South. Herein, we propose to develop and test a multi-
component communications intervention to promote uptake of a future HIV vaccine, as part of a
comprehensive set of strategies for HIV prevention, among Black women ages 18–34 in the South. Our
diverse team of HIV clinicians, behavioral scientists and health communication experts includes faculty from
Texas Southern University, the 2nd largest Historically Black College and University (HBCU) in the US. This
five-year study will take place in Houston, Texas, an epicenter of the HIV epidemic in the US South. We will
use community based participatory research methods (CBPR) and Community Engagement Studios to engage
young Black women in co-creating and testing communication content across multiple components (i.e., words,
graphics, videos). To increase uptake of a future HIV vaccine, we will conduct the following aims: 1) Assess
barriers and facilitators to uptake of a future HIV vaccine within the larger family of biomedical HIV prevention
tools, 2) Co-create theory-based message features (i.e., strategic word choice/ framing), graphics, and short
videos (30-120 seconds) for uptake of a future HIV vaccine. Theory-based features include enhanced active
choice, protective agency assignment, autonomy restoration, anticipated affect. 3) Evaluate the effect of
different theory-based message features, graphics and videos on HIV vaccine and prevention intention. We will
evaluate effects in three separate randomized trials of young Black women. This proposal takes a rigorous
approach to understanding the basic behavioral science of HIV vaccine communication. Communications
research is needed to understand how to develop messages that address distinct barriers to seeking out HIV
prevention (i.e., stigma, discrimination, medical mistrust, low risk perception, lack of awareness or knowledge)
and at the same time, leverage personal and social factors that resonate with Black women (e.g., social
networks, peer structures, and images and narratives that tap into the lived experiences of Black women). If
successful, this model of message design may translate to other long-acting forms of HIV prevention in
development (e.g. once a year implants, injectables, and broadly neutralizing antibody infusions).

Public health relevance
Project Narrative HIV disproportionately impacts young Black women in the Southern US. A future HIV vaccine could decrease disparities, but successful rollout will require communication that is strategic and tailored. We will use Community Engagement Studios to engage young Black women in developing communication strategies and content for increase uptake of a future HIV vaccine, within the larger family of HIV prevention tools. We will then test these communication strategies in three separate randomized trials to see what types of strategies have the great impact on HIV vaccine and prevention intention.